RFA-DP-22-001 DP006601 Component A - Core Surveillance - Washington Pregnancy Risk Assessment Monitoring System (PRAMS) RFA-DP-16-001

Washington State PRAMS Core Grant –Component A
Project Summary/Abstract PRAMS 2021 Grant
Project Title: Pregnancy Risk Assessment Monitoring System (PRAMS) (U01) Category B.
(Existing States) Washington State PRAMS 2021
Project Director: Teresa Vollan, PI/PD
Address: Washington State Department of Health
PO Box 47835
Olympia, WA 98504-7835
(360) 236-3585
Project Period: May 1, 2021 to April 30, 2026
The overall goal of Washington Pregnancy Risk Assessment Monitoring System (PRAMS) is:
To provide data to help develop and evaluate prevention and control measures, research
strategies, and policy options aimed at improving the health of women, infants and families in
Washington State. Survey participants, approximately 2,000 per year, are drawn from birth
certificate data using a stratified random selection based on race/ethnicity. The data collection
method for Washington PRAMS involves a statewide mailing of the questionnaire with
telephone follow-up for non-responders. Current aims are: 1) The Washington State PRAMS
Project will survey 2,000 recent mothers annually. 2) The Washington State PRAMS project will
analyze, interpret, and disseminate PRAMS data. 3) The Washington State PRAMS project will
utilize PRAMS data to plan and monitor programs and policies aimed at reducing health
problems among mothers and infants.

Public health relevance
Washington State PRAMS Component A [Core Surveillance] Grant 2021 Project Narrative The overall goal of Washington Pregnancy Risk Assessment Monitoring System (PRAMS) is to provide data that will influence program strategies, and policies that impact the health of women, infants and families in Washington State. The PRAMS survey provides a unique source of data on the behaviors and experiences of women before, during and just after delivery that is not available from any other source at the state level. This purpose of this proposal is to continue the PRAMs survey in Washington State. Approximately 2,000 Washington resident mothers per year are drawn from birth certificate data using a stratified random selection based on race/ethnicity. With a response rate of 55%, we are expecting that 1,100 women will participate in the survey. The data collection method for Washington PRAMS will involves a statewide mailing of the questionnaire with either a telephone or web-based survey as follow-up for non-responders. Completed surveys are cleaned by CDC, linked to the annual birth certificate file and weighted for non-response, an analytic file is sent to Washington PRAMS. Once Washington State receives the final analytic file from CDC we will analyze, interpret, and disseminate PRAMS data. The Washington State PRAMS project will utilize PRAMS data to plan and monitor programs and policies aimed at reducing health problems among mothers and infants.